Molecular mechanisms of ARF family GTPases

Project Summary/Abstract
Members of the ARF family of regulatory GTPases function as nodes in cell signaling to
coordinate essential cell processes; including membrane traffic, energy metabolism,
ciliogenesis, and the cytoskeleton. I have studied first ARF and later ARF-like (ARL) proteins for
over 30 years, using a combination of biochemical, cell and molecular biological, genetic, and
phylogenetic approaches and propose to continue these studies with a focus on their actions
linked to cilia and centrosomes to allow more detailed mechanistic studies of a subset of five of
the 30 GTPases in this family. We will use genome editing to generate a collection of knockout
cell lines to decipher signaling by the proteins under study. And we will use classical protein
biochemistry to purify and discover novel components in these pathways. We will both study
functions of each of these five GTPases in cells, and link to in vitro biochemical studies of their
enzymology. We will explore the potential for cross-talk or higher level ordering of cell signaling,
and also develop novel, single actions for atypical GTPases as a means of determining shared
or unique mechanisms within the family. A better understanding of these systems will reveal
novel insights into fundamental aspects of cell biology as well as providing potential targets for
intervention to alter the course of human diseases; including but not limited to cancer, heart
disease, neurodegeneration, ciliopathies, retinal degeneration, and deafness.

Public health relevance
Project narrative Essential cellular processes common to all cells are often controlled by GTPases within the ARF family and dysfunction in these regulatory systems result in human diseases ranging from cancer, heart disease, neurodegeneration, retinal degeneration, and deafness. We propose to determine molecular mechanisms by which these GTPases act and consequences at the cellular level when they dysfunction. As a result, we hope to discover fundamental aspects of cell biology that are relevant to understanding and treating a host of human conditions and also allow us and others to decipher fundamental concepts involved in cell regulation.